Education and Outreach to Tribal Producers through the Tribal Food Safety Alliance

Summary of Work Proposed
Through this project, the Indigenous Food and Agriculture Initiative (IFAI) at the University
of Arkansas, the Intertribal Agriculture Council (IAC), and the Federally Recognized Tribes
Extension Program (FRTEP) at the University of Arizona will continue the work of the
nation’s first Native Food Safety Alliance (NFSA). Together, these three organizations will
continue address the unique, specialized needs of American Indian and Alaska Native
(AIAN) food producers and food businesses, providing training and education on food safety
and ensuring that Indian Country has access to a reliable bench of culturally competent
trainers with food safety expertise and a thorough understanding of the way that the Food
Safety Modernization Act (FSMA) rules will impact their operations. To address these
specialized needs, our organizations invite FDA to continue this partnership and the work of
the TFSA to provide dedicated and culturally relevant food safety training, education, and
outreach to Indian Country stakeholders. Our overarching goal for TFSA has and continues
to be providing Native growers and food business owners across Indian Country with the
kind of culturally appropriate training, education, and outreach on food safety that will help
them be successful in the marketplace. This goal aligns well with FDA’s goal through these
agreements, to enhance the fundamental knowledge of food safety and especially on-farm
good agricultural practices of tribal stakeholders subject to applicable FSMA regulations. The
continuation of this Native Food Safety Alliance will help FDA continue to support a
nationally integrated food safety system in a way that makes certain that cultural practices
around food and principles of indigenous food science are accounted for and respected in
training and implementation.

Public health relevance
Project Narrative If funded, this cooperative agreement between the Indigenous Food and Agriculture Initiative (IFAI) at the University of Arkansas and the U.S. Food and Drug Administration (FDA) will ensure that American Indian and Alaska Native (AIAN) food producers and agribusinesses across the United States have access to the specialized food safety training they need to be successful in today’s marketplace. Indian Country contributes over $3.5 billion in raw agricultural products to the U.S. economy annually, making AIAN producers and food businesses a key stakeholder in ongoing food safety modernization activities. The creation of the Tribal Food Safety Alliance proposed by this cooperative agreement will contribute to public health by ensuring that Indian Country farmers, ranchers, and food businesses are incorporated into the nationally integrated food safety system envisioned by FDA, reducing the threat of foodborne illness outbreaks and improving the response rate for any outbreaks or recalls, especially in rural and remote parts of the country.